Identifying and understanding drivers of selection bias and information bias in clinical COVID-19 data

Project Summary / Abstract
During the COVID-19 pandemic, there is an immediate need for high-quality data for studies that
support patient care, predict outcomes, identify and evaluate treatments, allocate resources, and make
operations and policy decisions. While prospective research produces higher-quality evidence, retrospective
studies that reuse clinical data can be executed in a shorter time frame and for less cost, both of which are
crucial for research in a pandemic. Unfortunately, it has been shown that the usefulness and validity of
available COVID-19 data are constrained by various forms of selection bias and information bias, which may
lead to non-valid findings in research and analytics and disparities in resulting healthcare practices.
The objective of the proposed work is to study the selection and information biases present in clinically
derived COVID-19 datasets by integrating COVID-19 datasets from OHSU and the National COVID Cohort
Collaborative with novel and traditional sources of clinical, epidemiological, social media, and citizen-generated
data. From each data source we will extract data indicating COVID-19, as well as a set of social determinants
of health that are commonly associated with healthcare utilization and access. To test for the presence of
selection bias, we will construct and compare categorical probability distributions for each social determinant
across COVID-19 cases in each data source. Differences in these distributions will indicate selection bias in
one or more of the data sources. Next we will determine information bias by extending and adapting tests for
missingness and other forms of information bias in the COVID-19 datasets to determine if the quantity and
quality of these data vary with respect to clinical factors and those related to social determinants of health.
This proposal therefore addresses a significant gap in knowledge: understanding not just the disparities
in who is impacted by COVID-19, but who is represented by the data we have available for learning more
about the disease. The identification and estimation the influence of social determinants of health on selection
bias and information bias in COVID-19 data can guide the use of statistical and analytic approaches that can
improve the external and internal validity of research and analytics that rely on these data, including estimates
of disease prevalence, understanding the natural course of COVID-19, and identifying patients who are at risk
for severe disease.

Public health relevance
Project Narrative Certain demographic, social, and behavioral factors can lead to differences in which individuals with COVID-19 seek and receive testing or care (selection bias), as well as differences in the quantity and quality of data that are collected for those who do receive testing or care (information bias). Both types of bias may lead to disparities in healthcare and non-valid findings in research and analytics. The purpose of this work is to identify and explore potential drivers (like race, ethnicity, sex, or age) of selection bias and information bias in COVID- 19 data, with the goal of making findings from research conducted using these COVID-19 datasets more meaningful and trustworthy.